Shared Resource: Comparative Medicine

PROJECT SUMMARY: COMPARATIVE MEDICINE SHARED RESOURCE (CMSR)
The Comparative Medicine Shared Resource (CMSR), located at the Fred Hutch (FH), provides high quality
support for preclinical research performed by Consortium investigators. It achieves this through specialized
support structures, technology, and personnel expertise. CMSR maintains an AAALAC-accredited, USDA-
registered, and PHS-assured facility. CMSR is staffed by three clinical veterinarians with expertise in laboratory
animal medicine, animal-use regulations, and facility management and husbandry. An additional 45 personnel
provide daily care and treatment to five species of animals currently housed at FH – mice, rats, dogs, fish, and
guinea pigs – and deliver exceptional husbandry to maintain microbiologic and environmental control of animal
colonies. This care encompasses the needs of many specialized animal models of cancer and cancer-related
disease states such as transplanted or induced liquid and solid tumors, cancer-related pathogens, graft-
versus-host disease, and conditions and treatments related to radiation therapy. The small animal facility is a
centralized barrier facility with special areas to accommodate radioactive agents and infectious agents. CMSR
specialty services include patient-derived-xenograft (PDX) models and preclinical imaging support in
collaboration with the Translational BioImaging Core Shared Resource (TBICSR). A full time veterinary
comparative pathologist is available for consultation and collaboration with researchers. Equipment support for
CMSR includes individually ventilated micro-isolator rodent cages, a full service rodent cage wash and
autoclaves, and numerous surgical-ready procedure rooms for rodent users. Canine support includes
specialized housing for Severe Combined Immune Deficiency (SCID) and Pyruvate Kinase (PK) deficient
animals, a comprehensive surgical suite and procedure area, and a Linear Accelerator dedicated to preclinical
research. CMSR supplies an invaluable, centralized resource to support high quality preclinical studies.
Historically, animal models contributed to Nobel Prize winning research in bone marrow transplantation and
hematopoietic cancers. The continued expansion of scope and volume of animal-related work now includes
solid tumor and cancer-related pathogen research.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.